Neurobiology of hormonal contraception

PROJECT SUMMARY/ABSTRACT
During K23 funding, I will become an independent investigator focusing on the neural effects of sex steroids and
their analogues as they relate to behavioral processes. My research aims to improve gonadal steroid
manipulations across the female lifespan. As a critical first step, this research plan will evaluate the effect of
hormonal contraception on reward processing in the brain and assess its relationship to behavioral side effects
and patient utilization. Behavioral side effects of hormonal contraception such as negative mood and decreased
sexual desire represent some of the most frequently cited reasons for discontinuation. Discontinuation of
hormonal contraception is a known risk factor for unintended pregnancies. In order to personalize treatment that
limits such side effects as well as improve tolerability of future agents, progress in steroid neuroscience is
necessary. Current understanding of how hormonal contraception influences brain function has been limited by
a lack of prospective controlled investigations. Utilizing a placebo-controlled design, this project will be the first
to elucidate how a common oral contraceptive agent containing ethynyl estradiol and levonorgestrel (EE/LNG)
influences brain reward function via both neuroimaging and behavioral assessment. This research will reveal
how EE/LNG affects ecologically relevant behaviors (i.e., motivation, sexual function) in reproductive women,
and serve as the basis for investigation of other steroid contraceptive agents on these processes.
My research background in behavioral neuroscience combined with my clinical interests in women’s behavioral
health eventually led to my current focus in psychoneuroendocrinology. Now, as an Assistant Professor at the
University of Colorado Anschutz Medical Campus (CU-AMC), I have significant support and resources to train
to independence utilizing the K23 mechanism. My mentorship team is led by C. Neill Epperson, M.D. and
includes experts in neuroimaging (Drs. Tregellas and Epperson), sex steroids (Drs. Epperson and Santoro), and
statistical modeling (Dr. Sammel). My training objectives include deepening my understanding of: 1)
neurobehavioral effects of sex steroids; 2) advanced techniques in neuroimaging and 3) clinical trials and
statistical modeling. I will also 4) improve my research collaborating, writing and presentation skills and 5) obtain
additional training in the responsible conduct of research. I will accomplish these training objectives through
coursework and seminars, guidance from mentors/consultants, and completion of the proposed research.

Public health relevance
PROJECT NARRATIVE Effective use of hormonal contraception is frequently limited by behavioral side effects, such as changes in mood and decreases in sexual desire. These side effects may be attributable to the ways hormonal contraception impacts brain functions related to motivation and pleasure, known as “reward function.” This project will use a placebo-controlled design to evaluate the effects of hormonal contraception on reward function, with the goal of creating a protocol that will enhance personalization of contraceptive treatment, allowing clinicians and patients to better choose agents with the least propensity for behavioral side effects.